STUDIES IN MATHEMATICAL PHYSICS

The major emphasis of this project is on reaction kinetics in chemistry, particularly in low dimensional systems. Some work has also been done on models for diffusive transport in a disordered medium. Continuing some earlier work, PSL, together with a number of collaborators has done extensive work on characterizing intermolecular distances in reactions occurring in low dimensions. It has been shown that in a one dimensional system of the form A+B-B, with a single diffusing B molecule in the presence of many diffusing A molecules, the distance from the B to the nearest unreacted A molecule is proportional to a power of the time that varies between 1/4 and 1/2. A theory has been developed for diffusion in the presence of a molecule with a non-Markovian boundary. An international conference on non-classical chemical kinetics has been organized by the PSL, and will be held at NIH in March 1991.